Preclinical Research to Determine Prosthetic Joint Infection Pathophysiology Needed to Direct Clinical Bacteriophage Therapy

Abstract:
Prosthetic joint infections (PJI) are a devastating complication of arthroplasty surgery
that can lead to tremendous morbidity and mortality that rivals that of some cancers. The
reason PJI are so arduous to treat is secondary to high antibiotic tolerance of biofilm.
Consequently, novel therapeutics are needed to improve the outcomes of patients with PJI. One
such novel therapeutic is bacteriophage therapy, which have innate anti-biofilm capabilities.
However, many aspects of bacteriophage therapy are not well understood leading to poorly
reproducible protocols. The objective of this proposal is to address the several gaps in
knowledge that are currently present to help devise bacteriophage treatment protocols for PJI.
First, the PIs will evaluate whether S. aureus PJI are clonal or polyclonal infections using whole
genomic sequencing on S. aureus PJI clinical isolates. Additionally, the PIs will evaluate the
location of biofilm formation in PJI by visualizing biofilm formation on explanted PJI prosthetics.
Finally, to determine an effective route of bacteriophage therapy administration and to ensure
phage treatment is effective at the locations that biofilm forms on implants in vivo, the PIs will
evaluate the efficacy of bacteriophage therapy in reducing biofilm burden using different routes
of bacteriophage administration in a murine PJI model. These will also be correlated with the
production of neutralizing antibody production. Our working hypotheses are that (1) S. aureus
PJI are clonal infections, (2) biofilms on infected prosthetics will be located on both the
prosthetic-synovial interface as well as are located on bone-implant interface where it is not
assessable with debridement surgery and (3) the most effective mode of administration will be
intraarticular and repeated intravenous administrations, but this will come with a trade-off
associated with higher degree of neutralizing antibody production compared to other modes of
administration. The expected outcome of this proposal is to gain improved understanding of PJI
and how best to use bacteriophages in PJI. As well, this work will improve our understanding of
bacteriophage therapy to achieve our long-term goal to develop new, more effective treatment
strategies for PJI as well as to better enhance the use of bacteriophages in other MSK
infections.

Public health relevance
PROJECT NARRATIVE: Prosthetic joint infections are one of the most feared complications in total joint replacement, resulting in prolonged and costly treatment with unacceptably high treatment failure rates as a result of antibiotic tolerant biofilm. Bacteriophage therapy is a promising novel therapeutic with anti-biofilm activity, however many aspects of this therapy are poorly understood. There are multiple gaps in knowledge that limit the development of bacteriophage treatment protocols for periprosthetic joint infection. These include understanding the genetic diversity of bacteria during infection and the optimal routes for dose administration. Improved understanding of prosthetic joint infection pathophysiology and knowledge gained from animal models will allow for creation of effective and reproducible PJI-bacteriophage protocols, contributing to our ultimate goal of expanding treatment options not only in PJI but across the field of musculoskeletal infections.